Interactive Outbreak Simulator: A Robust and Customizable Platform for Socio-Epidemiological Insights

Project Summary / Abstract
The long-term objectives of this work are to develop a platform for modeling disease transmission during
outbreaks, and to deploy that platform into research laboratories and public health settings across the United
States. Through these objectives we will accomplish our goal of providing critical insights into how disease
spreads through different population compartments and the effects of various intervention strategies. Stratifying
the population into compartments based on risk status or social determinants of health including including
social vulnerability index, front line workers, pregnant individuals, children, and the elderly, will help us
understand if targeting interventions toward areas of health disparity will have greater effect in slowing the
spread of disease. These insights ultimately will give researchers and public health experts the tools to make
real time decisions and better forecast uncertain outcomes when data is limited.
The work proposed here builds off a previous collaboration and a prototype platform. The proposed work is
divided into three Specific Aims. In Aim #1, we will transform and re-architect the front and back ends of the
platform to standardize the data model to improve efficiency and compatibility with established visualization
libraries, enable modeling of all US states at a range of scales – including statewide, metro areas, and cities,
by county, zip code, or census tract, and add support for simulation concurrency and checkpointing, driving
scalability and robustness. In Aim #2 we will write new functions to ingest additional data sources, including
social vulnerability index and others, develop a toolkit to help other researchers augment the existing models
with custom disease models, travel models, and intervention strategy models, and expand on the existing unit
and functional tests to increase code coverage and improve documentation for future contributors. Finally, in
Aim #3, we will leverage our existing network of epidemiological researchers and public health experts in order
to perform hands-on testing, gather feedback, and refine the platform interface and functionality, and optimize
the deployment strategies for single-user and multi-user environments in real-world settings to ensure
reproducibility and foster a community-driven approach.

Public health relevance
Project Narrative Large-scale infectious disease outbreaks pose significant threats to public health and require robust simulation tools to advance scientific understanding. The proposed work develops and deploys an open-source, modular, and extensible software platform that empowers researchers of all skill levels to conduct simulations, test hypotheses, and validate models of disease transmission and intervention strategies. By equipping the research community with these capabilities, the platform will foster discovery, enhance reproducibility, and accelerate the advancement of epidemiological science.